An Intervention for Chronic Pelvic Pain

ABSTRACT: Chronic Pelvic Pain (CPP) is a debilitating problem that afflicts 15-20% of reproductive age
women.1 The significant suffering it causes leads to multiple surgeries and long-term medical therapies at a
cost of at least $2.8 billion annually, and many women undergo hysterectomy with consequential fertility
implications in hopes of pain resolution.1 Pain and suffering often persist despite treatment, and lead to
decreased productivity and reduced quality of life.2,3 The limitations of current surgical and pharmacologic
treatments for CPP have been well documented.
One of the most significant clinical challenges in CPP is predicting which treatment is likely to be effective for
an individual patient, due in large part to the heterogeneity of CPP. Management of other chronic conditions
has improved with development of clinical phenotypes, which help clinicians more quickly match patients with
effective treatments. However, clinical phenotypes have not yet been extensively explored in CPP.
Cognitive Behavioral Therapy (CBT), acupressure, and physical activity interventions have been shown to be
effective in a wide range of chronic pain conditions.4-6 Among patients with CPP, several small studies have
demonstrated efficacy of CBT, acupressure, and physical activity interventions.7-12 Effect sizes of individual
non-pharmacologic interventions are typically small (0.15-0.3).13-15 However, interventions that integrate
several of these modalities appear to have substantially improved efficacy (0.3-0.8),16-19 indicating possible
synergistic rather than additive effects. Web-based self-management programs help to reduce barriers to
access and many have been shown to be as effective as traditional face-to-face interventions.9,20,21 Our project
will build upon Fibroguide, a successful web-based cognitive/behaviorally-focused self-management program
for fibromyalgia. Patients with fibromyalgia demonstrated improvements in pain (0.64) and physical function
(0.38) utilizing Fibroguide compared to usual care.20
We propose to develop a web-based, self-management program for patients with CPP and to conduct a pilot
randomized controlled trial to evaluate preliminary effectiveness of the intervention and phenotypic factors that
predict positive response. Our overall hypothesis is patients with CPP will find a web-based self-management
program to be a valuable treatment strategy, and that patients who participate in this program will demonstrate
improvements in pain, physical function, and quality of life with this integrative self-management approach.
This project will generate preliminary data to support an R01 application to perform an RCT efficacy trial with a
focus on patient phenotyping and will ensure that the candidate has the skills to conduct independent research
in development and evaluation of personalized therapies for CPP.

Public health relevance
PROJECT NARRATIVE: The proposed research is highly relevant to public health as chronic pelvic pain afflicts 15-20% of reproductive age women and is associated with decreased productivity, reduced quality of life, multiple surgeries with consequential fertility implications, and long-term medical therapies at a cost of at least $2.8 billion annually. Development of effective, personalized treatment options for chronic pelvic pain is critically important. There is increasing evidence supporting use of non-pharmacologic therapies in chronic pelvic pain and other conditions, but their use is frequently hampered by limited availability of providers, particularly in underserved areas, lack of insurance coverage, and out-of-pocket costs. Web-based delivery of these bundled non-pharmacologic therapies is ideal because it allows expanded access with essentially fixed costs. This research proposes to develop a web-based integrative self-management program for chronic pelvic pain utilizing cognitive/behavioral, acupressure, and physical activity modalities and evaluate program effectiveness and patient phenotypic factors associated with symptom improvement.